LESION T CELL RESPONSE TO HSV IN HIV INFECTION

This proposal is directed at discovering the mechanism(s) by which human immunodeficiency virus (HIV) causes severe recurrent herpes simplex virus (HSV) infection. Recurrent HSV disease has a remarkable spectrum of disease severity in HIV-seropositive people. Recent studies indicate that people with both early and late HIV infection experience longer, and more frequent, asymptomatic and symptomatic HSV reactivation episodes as compared to HIV-seronegative people. PBMC immune responses to HSV have not been correlated with disease severity. To address host responses at cutaneous HSV recurrence sites, we have developed methods to study HSV- specific lesion-infiltrating T cells. This infiltrate is predominantly CD4+ in HIV-seronegative people. A ThO-like pattern of local cytokine responses and T cell receptor (TCR) gamma-delta+ cells reactive with HSV have also been detected. We hypothesize that quantitative or qualitative defects in local HSV-specific responses are associated with worsening of HSV disease, and propose extension of our studies to HIV-seropositive people. Preliminary studies have utilized specimens from HIV-infected persons with mild HSV disease. Both CD4+ and CD8+ HSV-specific lymphocytes were recovered, with a possible increase in CD8+,T cells from patients with lower CD4 cell counts. Infiltration of HSV lesions by specific T cells was preserved in patients who had lost PBMC responses to HSV antigen. The recovery of TCR gamma-delta+ cells from lesions has been lower from HIV-infected than from HIV-seronegative persons. Cytokine measures suggest a possible shift to a Th2-like pattern. In addition to changes in the antigen-specific T cell infiltrate, effects of HIV infection may include,apoptosis or replication of HIV in HSV-specific CD4+ cells activated within lesions. Lesion-resident antigen presenting cells may also be effected. The goals of this proposal are 1) to characterize lesion immune responses to HSV in HIV-infected persons, 2) to determine if HSV-specific CD4+ T cells within recurrent HSV lesions show evidence of apoptosis or HIV replication, 3) to evaluate cytokines patterns within recurrent HSV lesions from HIV-infected persons, and 4) to measure the ability of cutaneous APC from HIV-infected persons to present antigen to HSV-specific T cells. We will evaluate HIV-infected patients both with and without severe HSV disease, and compare our findings to responses from HIV-seronegative people. HSV is a unique OI because antigen-specific CD4+ T cells preferentially and predictably localize to an accessible site. The presence of HSV disease in many HIV-seronegative people, in contrast to some other HIV-related OI, provides an optimal control group. Recurrent HSV infection therefore presents a timely opportunity to evaluate the mechanism(s) by which HIV-induced immunosuppression leads to a clinically significant opportunistic infection.